Biostatistics Shared Resource

BIOSTATISTICS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Biostatistics Shared Resource (BSR) was established in 1995 to provide comprehensive, effective, timely,
and cost-effective biostatistical support to Yale Cancer Center (YCC) investigators who span across the entire
university. It is affiliated with the Yale Center for Analytical Sciences (YCAS), which covers all collaborative
biostatistics efforts at the Yale School of Medicine (YSM) and Yale School of Public Health (YSPH) under one
umbrella and has the YSPH Department of Biostatistics as its academic home. The BSR has a highly
experienced and interactive team of biostatisticians and bioinformaticians who work collaboratively with basic,
clinical, translational, and population science researchers to advance the frontiers of cancer medicine and public
health. The BSR faculty also offer workshops, office consultations, lectures, seminars, Grand Rounds, and
courses on study design, analysis methods, and software implementation to medical students, fellows, research
staff, and faculty. Shuangge Ma, PhD, Professor and Department Chair of Biostatistics with an outstanding
research record in cancer genetic epidemiology, population study, and bioinformatics, has been leading the BSR
since 2016.
During the most recent funding period, we have witnessed a steady increase in the demand for biostatistical and
bioinformatics support. Our biostatisticians have been providing strong and comprehensive support to multi-
investigator large projects (such as the SPOREs), R01-type projects, and developmental/pilot studies. We have
further strengthened bioinformatics support, especially for projects that also have significant biostatistical
components. Ma has served as the gatekeeper for all cancer-related bioinformatics needs for the YCC, to
facilitate collaborations among multiple bioinformatics groups and ensure non-overlapping support. Other
notable accomplishments include added expertise (in protocol review/development, data science, imaging data
analysis, and others), additional infrastructure building, and more effective management.
The Specific Aims of the BSR are to: 1) Provide powerful, comprehensive, and timely biostatistical and
bioinformatics support to all YCC investigators and projects; 2) Further strengthen in the areas of bioinformatics,
clinical trials, and multi-investigator studies; 3) Further reinforce our strong ties with YCC programs, other shared
resources, YSM, YSPH, and cancer biostatisticians/programs nationwide; 4) Develop leading-edge methods and
software to more effectively support cancer research; 5) Provide training in standard and advanced analytic
techniques to cancer students, fellows, research staff, and faculty, via workshops, office consultations, seminars,
Grand Rounds, lectures, and courses.
Over time, the BSR has been established as an essential component of YCC, and it will play an increasingly
important role in the next funding period.

Public health relevance
BIOSTATISTICS SHARED RESOURCE – NARRATIVE Not applicable.